Central regulation of atherosclerosis by testosterone-deficiency

Project Summary
This proposal delineates a 4-year research career development program focused on brain mechanisms by
which sex steroids protect from atherosclerosis. The candidate is currently a Research Assistant Professor in
the Department of Medicine, Division of Metabolism, Endocrinology and Nutrition at University of Washington
(UW). The proposed experiments and didactic work will provide the candidate with a unique set of multi-
disciplinary skills for him to become an independent investigator in the cardiovascular field. The candidate has
completed a PhD degree in Pharmacology at the University of Chile and two postdoctoral fellowships at OHSU
and UW. The applicant’s combination of expertise in sex steroids biology and CNS regulation of metabolism
uniquely qualify him to conduct these studies. In this proposal, he will address key questions in the field of
cardiovascular disease, the answers to which will increase our understanding of the relationship between
androgen deficiency and elevated cardiometabolic risk. Dr. Dorfman and his mentors (Drs. Karin E. Bornfeldt
and Joshua P. Thaler) have created a specific training plan that takes advantage of the intellectual resources
at the UW to guide him through the proposed educational activities and research. The goal of the current work
is to work in mouse models to identify CNS mechanisms by which hypogonadism increases the incidence of
cardiovascular events. Specifically, he will investigate the role of glial cells (microglia and astrocytes) in
cardiometabolic changes that accelerate the progression of atherosclerosis. The proposal focuses on human
evidence that low levels of circulating androgens promotes cardiometabolic dysregulation, and that
hypothalamic gliosis is associated with lower endogenous testosterone and plasma LDL in men. Furthermore,
the preliminary data identify a dramatic synergistic increase of hypothalamic gliosis when hypogonadism
induced by castration and Western-type diet are combined; in this animal model, early markers of
cardiometabolic risk are also evident including increased liver inflammation and triglyceride content, a shift
toward very low density lipoprotein species, and circulating leukocytosis. These findings support studies
proposed in Specific Aim 1 to use animal models with ablation of microglial or astrocyte inflammation to
determine whether hypothalamic gliosis is required for Western-type diet and androgen deficiency to
synergistically predispose to atherosclerosis. Additionally, the candidate has developed and validated a mouse
model in which microglia and astrocytes can be pharmacologically activated through the use of Designer
Receptors Exclusively Activated by Designer Drugs (DREADD) technology. These models of glial activation
provide a tool to determine whether gliosis is sufficient to increase the risk of CVD as proposed in Aim 2.

Public health relevance
Men with low levels of testosterone have substantially elevated risk of atherosclerosis, the leading cause of heart disease and stroke in the United States. Increasing evidence suggests that in addition to peripheral mechanisms, the brain also has the capacity to regulate risk factors of atherosclerosis. The proposed study aims to investigate hypothalamic gliosis as a pivotal mechanism through which testosterone deficiency promotes atherosclerosis.